Genomics and Transgenics

Development of congenic strains remains the most powerful tool to reduce an interval and demonstrate the mutation is present. For Project 1, we will reduce the interval from 13.2 Mb to <5Mb, and for Project 3 from 2.5 Mb to <Mb, yet to still retain the angiogenic phenotype. As we are looking to capture gene pathway information in addition to gene identification for Project 1, we will study a larger region;whereas. Project 3 is solely focused on the angiogenesis phenotype requires the finer resolution.